The epigenetic encoding of learning and memory

Abstract
The nervous system requires tight control of transcription for processes such as learning and memory
formation. The field of epigenetics seeks to understand how changes to gene transcription occur in response to
environmental cues and external signals such as those that our brains experience during learning. This proposal
lies at the intersection of neuroscience and epigenetics, with a particular focus on chromatin biology. Chromatin
is the complex of DNA and the histone proteins that wrap up DNA into complex structures, recruit key
transcriptional regulators, and in doing so, control gene expression. In recent years, it has become clear that
disruptions to chromatin regulation lead to a range of neurological and mental health disorders such as post-
traumatic stress disorder (PTSD). However, we have a limited understanding of how chromatin functions in the
brain or how its disruption can lead to disease. We will apply the tools and techniques of the epigenetics field to
the study of neuronal function. In doing so, we hope to elucidate the molecular mechanisms that allow our brains
to perform incredibly complex tasks and how disruption of these mechanisms can lead to neuronal dysfunction.
We propose overcome long-standing hurdles in the field using a combination of novel techniques to
reveal how the epigenetic landscape encodes the transcriptional changes that underlie memory formation.
Specifically, we seek to uncover the transcriptional signature of memory formation and memory maintenance
within single neurons in an in vivo context. We then will examine the epigenetic underpinnings of this
transcriptional signature and manipulate specific components of the chromatin environment to define their
contribution to learning and memory maintenance. First, in order to elucidate the gene program associated with
learning, we will use single-nucleus RNA-sequencing in combination with mouse models that label the specific
neurons activated during learning. This will allow us to examine the transcriptional programs activated in neurons
that form a memory engram compared to their neighboring cells at various times after learning. Next, we will
employ a quantitative biochemical approach uniquely available to our group as part of the Epigenetics Institute
to characterize the chromatin landscape changes the occur during memory formation, memory maintenance,
and reversal learning. Finally, we will modify the chromatin landscape by manipulating specific histone proteins
in combination with numerous sequencing approaches to elucidate how chromatin controls learning and the
transcriptional program. Employing this novel combination of techniques will allow us to uncover the mechanisms
through which the epigenome encodes information within neurons to modify behavior both in the context of
normal learning and in the context of maladaptive responses that lead to disorders such as PTSD. If successful,
these methods will 1) identify the transcriptional signature that encodes a memory in neurons, 2) map how this
signature is encoded by specific epigenetic regulatory mechanisms, and 3) define how the chromatin landscape
affects memory formation and contributes to mental health disorders.

Public health relevance
We work at the intersection of neuroscience and epigenetics which explores how our experiences and environment changes transcription of our genes. We seek to uncover the transcriptional signature encoding a memory within a neuron and how this is influenced by epigenetic mechanisms. Through this work, we hope to understand how the world around us influences gene regulation in the brain to allow us to learn, adapt, and become the people we are today.